Personalized bioprinting technology for de novo PDL regeneration

ABSTRACT
Avulsion of permanent teeth is one of the most serious dental injuries. The periodontal ligament
(PDL) is damaged and contaminated during avulsion and the outcome after replantation of the
avulsed teeth is poor. Cell-based therapy using PDL stem cells (PDLSCs) provides us with the
opportunity to regenerate the PDL of avulsed teeth. Recent large animal studies have shown
promise of cell-based therapies for managing avulsed teeth. However, there is a lack of
systematic design and deployment of the type of cutting-edge tissue engineering technology that
would ultimately lead to development of a personalized medicine approach for the de novo PDL
regeneration of avulsed teeth. Here we propose to incorporate a newly developed, two-step
technology, namely the use of Biosynspheres and personalized 3D-bioprinting for stem cell-
mediated PDL regeneration. The first step involves the production of bio-ink containing PDLSCs
encapsulated in microspheres, termed PDLSC-Biosynspheres. The second step employs a
custom-made 3D-bioprinter designed with specific algorithms that can print a layer of PDLSC-
Biosynspheres onto the decontaminated and denuded tooth root following its natural surface
topography, with a desired and uniformed thickness for PDL regeneration on the entire root
surface. We hypothesize that the lost PDL on avulsed teeth can be regenerated de novo using
personalized bioprinting with PDLSC-Biosynspheres. In Aim 1, we will optimize the generation of
PDLSC-Biosynspheres and characterize their biological behaviors after being printed onto the
root surface in vitro and with an established SCID mouse model in vivo. In Aim 2, we will utilize
a simple mini-swine model to characterize the regeneration of functional PDL in vivo. We
anticipate that the combination of PDLSC-Biosynspheres and personalized 3D-bioprinting
technology will result in consistent PDL regeneration on the root, which will generate preliminary
data that sets the stage for more extensive large animal studies in a future R01 application. The
significant clinical impact is the potential to establish a Dental Trauma Management Center at the
Tennessee Institute of Regenerative Medicine (TennIRM) for replanting avulsed teeth aiming at
successful long-term favorable outcomes. Future endeavor will include establishing stem cell
banking to facilitate and secure the cell source for such medical therapies.

Public health relevance
Narrative Replanting the tooth that got knocked out back to the tooth socket seldom leads to favorable outcomes and often resulting in tooth loss which affects jaw development or stability. Here we are working on a new clinical protocol using cutting edge 3D cell encapsulation and personalized bioprinting technologies to print dental cells to the individual knocked-out tooth to achieve successful dental tissue regeneration and retain the replanted tooth. A Dental Trauma Management Center may be established to served needed patients nation-wide.